Restoring hair follicle stem cell fate and heterogeneity outside their native niche

PROJECT SUMMARY
Adult stem cells (SCs) reside in defined niches and depend on microenvironmental cues to instruct their behavior.
The hair follicle (HF) is an excellent model system to study a rich set of SC-niche interactions as it undergoes
stereotypic regenerative cycles. This self-contained mini-organ utilizes high levels of spatial organization and
compartmentalization to promote SC fate determination along HF lineages. However, when hair follicle stem
cells (HFSCs) become isolated from their niche, they lose their identity and display a wide-ranging plasticity that
can produce all lineages of the skin. This multipotent state has long acted as a barrier to restoring HFSC identity
when the niche becomes disrupted, despite a wealth of information regarding the signals that control HFSC
behavior. To overcome this challenge, I have built upon our lab’s recent discovery that cultured HFSCs exhibit
a wound-like epigenetic signature and hypothesized that targeting the pathways responsible for driving the
wound response would permit the re-acquisition of HFSC identity. Here, I present here the development of a
platform that reinstates the homeostatic identify of HFSCs, made possible through my identification of niche
signals that lie at the intersection between tissue regeneration and wound-related plasticity. My preliminary data
demonstrate the efficacy of targeting these pathways to resolve the wound signature and restore their sensitivity
to local cues that support the acquisition of a full suite of differentiated HF cell types. In this proposal, I will
examine the resulting heterogeneity of HFSC fates in response to optimized niche signals using single cell
transcriptomics. My developing bioinformatic skillset will allow me to compare these cell fates with their in vivo
counterparts (Aim I). Next, I will dissect the mechanistic role played by retinoic acid (RA), an essential metabolite
required for HFSC identity and self-renewal. By focusing on the transcriptional effectors of RA, I will functionally
define how RA availability impacts HF cycling and wound-induced follicular neogenesis (Aim II). Lastly, I will
apply this platform to human patient samples and functionally dissect HFSC interactions with their dermal niche
in newly engineered skin (Aim III). In total, this work will mechanistically define the minimal requirements
necessary for human HFSC self-renewal and differentiation. If successful, my research has the potential to
rapidly model and test hypotheses related to human HF disorders, accelerate therapeutic efforts aimed at
achieving HF morphogenesis, and ultimately regenerate the complete integumentary system.

Public health relevance
PROJECT NARRATIVE Hair follicle stem cells depend on environmental cues to instruct their behavior, as demonstrated by their acquisition of an unresolved, multipotent state after exiting the niche. In this proposal, I have developed a platform able to reinstate stem cell identity and direct a full suite of differentiated fates outside the niche. By clarifying the mechanistic underpinnings of these processes and applying this technology to the study of human stem cell interactions with their dermal niche, my work has the potential to dramatically improve our clinical understanding of stem cell biology and accelerate the development of therapies designed to treat hair follicle disorders and regenerate folliculogenic skin.